Defining Targets for Tic Detection and Suppression in Tourette Syndrome Deep Brain Stimulation

PROJECT SUMMARY
Tourette syndrome (TS) is a continuous lifelong condition that is highly prevalent, socially disabling, and in some severe
cases, physically injurious. DBS has emerged as a promising treatment option for addressing uncontrollable tics in medically
resistant and severe cases of TS frequently involving self-injurious behavior. We have undertaken a major informatics
initiative by establishing the International TS DBS Registry and Database, a multi-country consortium that has captured long
term outcomes of 277 TS DBS patients representing 50-75% of all TS DBS cases worldwide. From these outcomes, two
deep brain targets have emerged as potentially effective: the centromedian nucleus region (CM) of the thalamus, and the
anterior globus pallidus internus (aGPi). However, our current understanding of tic generation is limited by many factors
including a lack of animal models for TS, apparently normal brain structure on structural imaging, and the impracticality of
studying involuntary motor tics with functional imaging. Next generation closed-loop DBS systems can record brain activity
in patients with TS and identify the neurophysiological correlates of tics. Moreover, these devices can deliver stimulation in
response to a patient's symptomatic state. Our overall goal is to develop neurophysiology driven and connectivity-guided
closed-loop DBS systems for the improved treatment of TS. To this end, we will implant 8 medically resistant TS patients
with bilateral leads in the CM and aGPi. In Aim 1, we will identify structural network projections from CM and aGPi to guide
pre-operative surgical planning and post-operative selection of stimulation parameters. In Aim 2, we will identify
neurophysiologic correlates of tic genesis in the CM and aGPi. We will also study thalamo-pallidal network interactions
leading to and during tics. In Aim 3, we will test the feasibility, safety, and efficacy of closed-loop TS DBS. We expect that
closed-loop stimulation will provide more effective and personalized treatment options with longer battery life and fewer
adverse effects.

Public health relevance
PROJECT NARRATIVE The proposed research is directly relevant to public health because it will increase our understanding of the physiological underpinnings of Tourette Syndrome, and it will inform approaches for deep brain stimulation of different brain targets to both monitor and to suppress tics. This research will contribute to the development of personalized therapies, such as closed-loop deep brain stimulation, and the research will have the impact of improving quality of life for patients suffering from this disorder.